Structural biology of chromatin in vitro and in cells

Project Summary
The laboratory led by PI Galia Debelouchina has the following long-term objectives: 1) The development of
structural biology methodology to study complex and dynamic biological assemblies in vitro, and 2) The
extension of these methodologies for structural biology investigations in the cellular environment. Our
methodology development combines solid-state nuclear magnetic resonance (NMR) spectroscopy with state-
of-the-art chemical biology tools for the comprehensive description of biological systems both in vitro and in
cells. Over the next five years, we plan to accomplish the following goals: 1) Elucidate the molecular basis of
heterochromatin formation and regulation. Heterochromatin compartments are associated with gene silencing
and repetitive DNA sequences, and their formation is a vital step in cell differentiation and development.
Recent hypotheses suggest that they are formed through a process called liquid-liquid phase separation and
that a central player in this process is the heterochromatin protein 1 (HP1) family. Our goal is to understand
how HP1 proteins orchestrate a complex network of interactions with each other, with chromatin, and with
other protein binding partners to regulate the material properties of heterochromatin environments and their
implications for gene silencing. We will tackle this goal using NMR spectroscopy, chemical biology, cell biology
and computational tools to obtain a comprehensive molecular view of heterochromatin interactions. In the
process, we also hope to develop new NMR-based tools to characterize dynamic and heterogenous biological
systems such as those formed by HP1 proteins. 2) Development of NMR-based tools for structural biology in
cells. Here, we plan to focus on the development and implementation of a technique called targeted dynamic
nuclear polarization (DNP), which allows us to zoom in on a specific protein in the cellular environment and to
increase its NMR signals selectively over the cellular background. We plan to apply this technique to study
protein-membrane interactions in whole bacterial and mammalian cells. Ultimately, we aim to develop targeted
DNP as a tool to build an atomic resolution picture of the cellular milieu and to investigate changes in protein
structure and dynamics in health and disease.

Public health relevance
Project narrative This project will develop novel approaches to study complex biological assemblies both in vitro and in cells. We will apply these methodologies to study the principles of gene regulation and the interactions of proteins with cellular membranes. Understanding the complexity of biological interactions in a native context will shed light on normal cell development and on the molecular origins of disease.